Options for Pain Management using Nonpharmacological Strategies (OPTIONS)

Background: In response to opioid-related harms and evidence supporting nonpharmacological treatments
(NPTs) for chronic pain, VHA has prioritized multimodal pain treatment approaches that include evidence-
based NPTs. However, NPTs are persistently underutilized, and Veteran-level barriers remain largely
unaddressed. OPTIONS (Options for Pain management using Nonpharmacological Strategies) is focused on
overcoming Veteran-level barriers to NPT use and adherence with 1) a decision aid to help patients
understand and compare NPT options and find NPTs that work best with their goals and lifestyle, and 2) a
coach who uses motivational interviewing to foster self-efficacy, prepare Veterans to discuss NPTs with their
providers, and build patients’ confidence to manage their pain with NPTs.
Significance: OPTIONS is directly responsive to HSR&D’s Opioid Solicitation by focusing on behavioral health
and engagement of Veterans in non-medication treatments. OPTIONS also supports the 2016 Comprehensive
Addiction and Recovery Act and numerous VA directives focused on increasing availability of NPTs.
Innovation/Impact: Despite mounting evidence on the effectiveness of NPTs, there is a distinct lack of research
aimed at overcoming patient-level barriers to NPT use. This is a critical gap that impedes pain management
and the goal of reducing reliance on opioids. OPTIONS is the first study to use a tailored, patient-centered
approach to address patient-level barriers to uptake of and adherence to NPTs. As such, OPTIONS provides
an important complement to VA’s system-wide efforts aimed at promoting NPTs and helps ensure that VA’s
substantial investment in these initiatives leads to increased use of NPTs and improved Veteran outcomes.
Our partnership with VA Pain Management and the Office of Patient-Centered Care and Cultural
Transformation will facilitate implementation of OPTIONS by leveraging existing Whole Health coaches if it is a
positive trial—further enhancing the impact of this proposal.
Specific Aims: Aim 1: Test the OPTIONS intervention’s effects on pain interference (primary outcome) among
Veterans with chronic pain.
Aim 2: Test the OPTIONS intervention’s effects on NPT use and secondary outcomes (health-related quality of
life, psychological functioning, patient activation).
Aim 3: Identify facilitators and barriers to implementing the OPTIONS intervention.
Methodology: This Hybrid Type 1 study will test effectiveness while examining implementation facilitators and
barriers. 296 Veterans with chronic musculoskeletal pain will be randomized to the intervention (10 weeks of
coaching using motivational interviewing and the OPTIONS decision aid on NPTs) or to a waitlist control arm.
We will examine outcomes at baseline and 3, 6 and 9 months. In Aim 3, we will use qualitative methods to
understand facilitators and barriers to future implementation via interviews with a subset of intervention
Veterans and with PCPs whose patients received the OPTIONS intervention.
Implementation/Next Steps: Pending positive results, our next step will be a multi-site hybrid type 2
effectiveness-implementation trial, in which we will evaluate for implementation while continuing to test for
effectiveness. We will work with our operational partners to implement the OPTIONS intervention using
existing Whole Health Coaches, thereby helping to ensure sustainability. In addition, findings from Aim 3,
which examines barriers and facilitators to implementation, will help to guide these next steps.

Public health relevance
In response to widespread opioid-related harms and high-quality evidence supporting nonpharmacological treatments (NPTs) for chronic pain, VHA and other organizations have advanced policies to move away from opioid prescribing toward multimodal approaches to pain that prioritize evidence-based NPTs. However, NPTs are consistently underutilized, and chronic, disabling pain remains a persistent problem, affecting up to 66% of Veterans. Although VHA is addressing system-level barriers to NPT use through expansion of availability of complementary and integrative health therapies, Veteran-level barriers to NPT use and adherence remain. OPTIONS directly addresses Veteran-level barriers with an intervention consisting of individual coaching and a decision aid focused on available, evidence-based NPTs. OPTIONS directly addresses VA priorities of managing chronic pain and sustaining patient engagement in non-medication treatment.